Integrin-binding Peptide for Ocular Neovascularization and Macular Edema: Molecular Mechanism of Action

There is mounting evidence that integrins avl33 and a5131 play an important role in the
stimulation of retinal/choroidal neovascularization (NV) and vascular leakage, but there are gaps
in our knowledge of the mechanisms by which they act that this proposal seeks to clarify. A
collagen IV-derived peptide mimetic that blocks avl33 and a5131 and exerts strong antiangiogenic
and anti-permeability activity, AXT107, and newly developed analogs that have
different but overlapping activities, will be used as tools to facilitate those mechanistic studies. In
addition, suprachoroidal injection of AXT107 microparticles will be tested for sustained delivery
and prolonged suppression of NV and vascular leakage to take advantage of the therapeutic
potential of AXT107.

Public health relevance
Project Summary Retinal/choroidal vascular diseases including neovascular age-related macular degeneration (nAMD), diabetic macular edema (DME), and proliferative diabetic retinopathy (PDR) are prevalent causes of vision loss. Vascular endothelial growth factor-A (VEGF-A) is a key stimulator and intraocular injections of VEGFA antagonists provides great benefits. However, outcomes are suboptimal because other vasoactive factors contribute in some patients and because patients and physicians have difficulty maintaining the frequency of injections needed to control neovascularization (NV) and exudation. While Faricimab, which targets both VEGF-A and angiopoietin 2, may have slightly greater durability than specific VEGF-A antagonists, it does not provide better efficacy and there are many patients treated with Faricimab who have suboptimal outcomes. Treatments that target other contributing factors in addition to VEGFA and provide sustained release to reduce treatment burden are needed and this proposal addresses both of those needs. In the previous grant period, we demonstrated that AXT107, a collagen IV-derived 20-mer peptide mimetic, strongly suppresses NV and vascular leakage in models relevant to nAMD, DME, and PDR and elucidated part of its mechanism of action; it binds integrins αvβ3 and α5β1 and blocks their co-receptor functions resulting in suppression of VEGF and hepatocyte growth factor (HGF) signaling and conversion of angiopoietin 2 (Ang2) from a Tie2 antagonist to a Tie2 agonist. When injected into the vitreous of rabbits, AXT107 self-aggregated into a gel that slowly eroded providing sustained release and prolonged suppression of NV and vascular leakage. This led to clinical trials in nAMD and DME which demonstrated sustained suppression of exudation in many patients, but in some patients the gels were not compact and fragmented, resulting in dispersion of particles into the anterior chamber, occluding trabecular meshwork and increasing intraocular pressure. These studies have helped to validate αvβ3 and α5β1 as important therapeutic targets, but also demonstrated that more knowledge is needed to better understand exactly how they interact with RTKs, which interactions are important, and rationally design an antagonist that can be provided by sustained delivery. AXT107 is still a clinical candidate if a new sustained delivery approach can be developed, but in addition, it provides a tool along with newly developed analogs to further explore the mechanism by which antagonism of αvβ3 and α5β1 suppresses NV and exudation providing new knowledge that can guide development of improved next generation antagonists of αvβ3 and α5β1. Thus, this proposal will explore detailed mechanisms by which signaling through αvβ3 and α5β1 promote retinal/choroidal NV and exudation and how best to utilize that knowledge for design of therapeutic peptides, while at the same time solving issues related to delivery of AXT107 to allow additional clinical testing.